Longitudinal Study of Early NAFLD Progression and the Gut Microbiome in Asian Americans, Native Hawaiians and Whites

PROJECT SUMMARY / ABSTRACT
This Administrative Supplement application is submitted under PA-20-272 in response to NOT-AG-23-032. In
the parent project (R01 MD018265; 2022-2027; “APS2”), we are assessing the early progression of non-
alcoholic fatty liver disease (NAFLD) and liver fibrosis over 10 years from mid to late adulthood and evaluating
the role of the gut microbiome in mediating the effect of diet on the liver outcome in a subset of the population-
based Multiethnic Cohort (MEC) among Hawaii participants from three racial/ethnic groups (Asian, Native
Hawaiian, White) with known disparate susceptibility to NAFLD. In this supplement request, we propose to
investigate the relationship of the gut microbiome, NAFLD, and Alzheimer's disease and related dementias
(ADRD) in the full MEC and the baseline APS1. We showed an up to 2-fold difference in age-adjusted risk of
AD/ADRD across the five racial/ethnic groups in MEC based on Medicare claims data, with the highest risks and
the highest frequency of APOE ε4 risk allele carriers found among African Americans as previously reported and
also Native Hawaiians (Alzheimer's & Dementia 2022). While we replicated the association of known risk factors
with ADRD in the MEC (Alzheimer's & Dementia 2023), only one third of the 16,410 cases were explained by
known risk factors including APOE, and this population attributable fraction varied substantially by race/ethnicity.
These findings underscore the need to identify additional risk factors for ADRD, especially contributors to the
striking racial/ethnic disparities. Emerging evidence suggests that the highly prevalent NAFLD, detected in over
30% of older adults, is a risk factor for ADRD/dementia and that pro-inflammatory gut microbiota may promote
neuroinflammatory etiology of ADRD, corroborating the putative liver-brain axis. Thus, we propose to (Aim 1a)
evaluate the association of NAFLD with subsequent ADRD risk in a longitudinal analysis of the MEC cohort
(21,770 ADRD cases, over 20y of follow-up) and also to (Aim 1b) assess the relationship between an exclusive
biomarker of microbial inflammation (plasma LBP) and the NIA-designated sole clinical biomarker for neuro-
inflammation (plasma GFAP) in a nested case-control study of 500 pairs of ADRD cases and controls, composed
evenly of women and men and five racial/ethnic groups. Separately, in the subset of the 300 MEC participants
without history of ADRD who are being followed for the parent APS2, we will analyze the baseline APS1 data
and archived blood samples to (Aim 2) explore the relationship of 16S rRNA gene sequence-based gut microbial
features (alpha and beta diversity, taxa composition, imputed functions), MRI measurement of liver fat, and the
plasma neuroinflammation marker GFAP. The proposed study is within the scope and timeline of the parent
project supported by NIMHD to better understand the impact of the gut microbiome and NAFLD and to better
represent and promote racial/ethnic minority and rural population health. Findings from the supplement study
will be used to develop grant applications to further interrogate the link between gut health and ADRD etiology
and to devise lifestyle intervention strategies to improve the gut microbiome, resolve NAFLD, and prevent ADRD.

Public health relevance
PROEJCT NARRATIVE In the Multiethnic Cohort (MEC) based in Hawaii and Los Angeles, the risk of Alzheimer's disease and related dementias (ADRD) showed a two-fold difference by race/ethnicity; highest among African Americans and Native Hawaiians, lowest in Asian Americans, and intermediate in Latinos and Whites. Emerging evidence suggests that non-alcoholic fatty liver disease (NAFLD), detected in over 30% of older adults, increases the risk of ADRD, and that pro-inflammatory gut microbiota may be involved in the liver-brain connection. We propose to evaluate whether ADRD risk is higher among NAFLD patients in MEC, whether the exclusive blood marker for microbial inflammation is related to the blood marker for brain inflammation, and whether and how gut microbial characteristics (diversity, composition, functions) are related to the blood marker for brain inflammation.